R-loops at the telomere as a toxic source of genomic instability

PROJECT SUMMARY
Damage to telomeres resulting from radiation or exposure to toxic chemicals can lead to cancer and accelerated
aging. Damage may also result from normal metabolism including generation of formaldehyde or transcription
when RNA is left behind embedded in the DNA in the form of R-loops. Extensive studies of genomic R-loops
have shown them to play both positive roles in regulation of transcription and harmful roles leading to DNA
breakage, mutagenesis and cancer. Telomeric R-loops (tel-R-loops) may possibly be the single greatest source
of DNA damage at telomeres. Tel-R-loops occur in normal human cells, but are more abundant in cells
expressing the ALT cancer phenotype and cells mutated in DNA methylases that produce high levels of
telomeric RNA (TERRA). Elevated levels of tel-R-loops have been linked to telomere damage, shortening and
high recombination leading to cancer. Radiation, toxic agents such as cisplatin, formaldehyde, and exposure to
oxidative damage are also likely to generate higher levels of tel-R-loops. We demonstrated that telomeres are
arranged in large loops (t-loops) and recently made a paradigm-shifting discovery linking t-loop formation to
telomere transcription which generates TERRA and produces tel-R-loops which we propose are key to t-loop
formation. Thus, tel-R-loops are both toxic and necessary for forming protective t-loops. Tel-R-loops are more
stable than normal R-loops due to G-quartet formation. The extensive studies of genomic and tel-R-loops have
all relied on a single assay employing the S9.6 antibody to DNA/RNA hybrids (DRIP assay). While having driven
the field, this IP assay does not discriminate between one or many R-loops on a DNA fragment, or provide
information on the clustering of the R-loops, or their size. For tel-R-loops, the IP assay does not reveal whether
there are R-loops within the looped portion of the t-loop or their distribution from the sub-telomeric regions to the
telomere terminus. For the field to progress, such critical information must be obtained. This can now be done
using direct electron microscopic (EM) visualization using methods we have verified and in hand.
In the proposed work we will carry out a high resolution study of the large (120-240 nt) particles formed by
single stranded G-rich telomeric DNA and TERRA RNA. This is critical for understanding the structure of tel-R-
loops and will be done by cryoEM. To determine the frequency, location, size and clustering of tel-R-loops we
will apply a novel affinity isolation for telomeric DNA, combined with our battery of EM tools. This will be done
using cultured HeLa and human ALT cancer lines and extended to cells treated with toxic chemicals including
cisplatin and formaldehyde to introduce crosslinks in the DNA. A novel chemoptogenomic approach for placing
ROS generated 8-oxoG lesions specifically at the telomere in cells will be applied in a collaboration and the
effect on tel-R-loops determined. The t-loop junction may have important functional roles and this will be
explored using assays to detect telomere extension following cleavage of the t-loop junction by HJ resolvases.

Public health relevance
PROJECT NARRATIVE R-loops may be the greatest source of DNA damage at telomeres leading to cancer and accelerated aging. While known to occur and at high levels in the ALT cancer phenotype, almost nothing is known about their size, clustering, or location along the telomere or generation by toxic insult due to toxic chemicals or radiation. Our unique EM methods will answer these key questions, allowing rapid advancement of the field.